ADEPT-STAR therapy for high risk neuroblastoma

PROJECT SUMMARY
Cancer remains a primary health concern despite significant advancements in treatment. In the past decade, cell
and gene (C&G) therapies along with immuno-oncology (I-O) therapies have transformed treatment expectations
by extending cancer free survival and complete remissions. Despite these remarkable successes, they are limited
to a subset of cancers and many significant challenges remain for broader application and to unlock the perceived
medical and commercial potential. Expression Therapeutics, Inc. (ET) is a fully integrated C&G therapy company
addressing these unmet clinical needs by using proprietary and complementary platform technologies that
optimize therapeutic transgene expression and gene delivery for the development of off-the-shelf allogeneic-
based gene therapies. These technologies address major challenges being encountered in C&G I-O: identification
of safe and effective tumor targets, maximizing treatment durability and efficacy and reducing the cost of goods.
Results of preliminary in vitro and in vivo studies support feasibility of the proposed application and the successful
development of this robust platform for the treatment of pediatric neuroblastomas and other forms of
neuroendocrine tumors (NETs) proposed in this application.

Public health relevance
PROJECT SUMMARY Cell and gene (G&G) therapies have significantly improved the expected outcomes for a subset of cancers and has transformed the field of immuno-oncology (I-O). Despite tremendous clinical success, significant challenges remain for unlocking the therapeutic and commercial success of these therapies. Expression Therapeutics, Inc. (ET) is a fully integrated C&G therapy company addressing these therapeutic challenges using proprietary and complementary platform technologies that optimize transgene expression and gene delivery to off-the-shelf allogeneic T cells for the development of novel therapies for pediatric neuroblastomas and other forms of neuroendocrine tumors (NETs).